D2/5HT2 STIMULANT INDUCED CHANGES IN BSR

Increases in psychomotor stimulant abuse have lead to a national effort to curtail use of these substances. For the most part, recent efforts have focused on stemming the tide of cocaine abuse. Attempts have been made to reduce both the supply of and demand for cocaine. In addition, the search has begun for effective treatment programs for those who have developed chronic patterns of cocaine abuse. Pharmacological treatments are being viewed as a potentially important adjunct to behaviorally-oriented treatment strategies. Given recent evidence that the reinforcing effects of many drugs of abuse are mediated through a common neural substrate, drugs developed for the treatment of cocaine abuse may be useful for treating the abuse of other substances. The long-term objectives of the proposed research are an elucidation of the neural substrates/mechanisms which mediate psychomotor stimulant reinforcement, and the development of pharmacological treatments for psychomotor stimulant abuse. These objectives will be pursued in the following experiments. 1. One series of experiments will evaluate the role of the nucleus accumbens (and possibly other dopamine terminal fields) in the self- stimulation threshold-lowering effects of amphetamine and cocaine. These experiments are intended to identify the neuroanatomical loci that mediate cocaine and amphetamine's reinforcing effects by assessing the influence of 6-hydroxydopamine (6-OHDA) lesions on amphetamine and cocaine-induced enhancement of brain stimulation reward. 2. A subsequent series of experiments will focus on the capacity of mixed D2/5-HT2 antagonists to reverse amphetamine and cocaine-induced decreases in self-stimulation thresholds. Preliminary evidence suggests that these drugs attenuate the reinforcing properties of psychomotor stimulants. The proposed experiments will systematically investigate the ability of compounds with varying specificity for the D2 and 5-HT2 receptor subtypes to antagonize cocaine and amphetamine's effects on brain stimulation reward. The relative contribution of dopamine and serotonin mechanisms will be clarified by using antagonists that differ in their spectra of dopaminergic and serotonergic activity. 3. A set of neurochemical and electrophysiological experiments will be performed based on the outcomes of the 6-OHDA and antagonist studies. These experiments will be conducted to elucidate the mechanism(s) by which an antagonist reverses cocaine or amphetamine's effects. Drug-induced changes in dopamine metabolism an release will be measured using in vivo microdialysis, while extracellular recording techniques will be used to measure dopamine cell activity. The neuroanatomical loci for the microdialysis and recording studies will be determined by the 6-OHDA experiments, and the antagonists will be selected based on their ability to reverse cocaine or amphetamine's effects on self-stimulation thresholds. The combination of behavioral, neurochemical and electrophysiological techniques used in the proposed experiments should provide insights into dopaminergic and serotonergic modulation of psychomotor stimulant reinforcement. In addition, these experiments will provide information concerning the potential value of D2 and 5-HT2 antagonists as pharmacotherapies for psychomotor stimulant abuse.